Training Systems and Integrative Neuroscience

This is a competing renewal application for funds to support pre- and postdoctoral training in Integrative
Neuroscience at the Center for Neural Science at New York University. This proposal aims to continue and
enhance a successful implementation of our training program focused on four interrelated core areas of
investigation: learning, memory, development and plasticity. The proposed training program includes a
partnership with the Graduate Program in Neuroscience and Physiology at the NYU School of Medicine. We
seek to renew our support at the level of 5 predoctoral and 2 postdoctoral fellows. This number of trainees
requested is based primarily on the importance of fostering a cohesive training group of a sufficient size to
support trainee development across levels, from pre to post-doctoral and from cellular-molecular to systems
and cognitive approaches, across program divisions, and between translational and basic research. This
represents an increase of one trainee, with a clinical/translational focus. Our proposed training program will
provide a central focus for pre and postdoctoral training in areas of neuroscience critical to advancing
knowledge of development and degeneration of the nervous system, neural disease processes, and
disorders of memory and mental health. Our trainees will have the opportunity to be a part of a cohort of
world class scientists engaged in cutting-edge research related to learning, memory, development and
plasticity. We have compiled a group of 26 training faculty that will provide an integrative, collaborative
training experience that crosses traditional disciplinary boundaries, spans levels of analysis, and levels of
training. The trainees, predoctoral fellows in the third year or higher and postdoctoral fellows in the early
years post-PhD, will have access to a special seminar series, individualized mentoring, opportunities to
develop translational thinking, and workshops to promote balanced professional and academic skills
important for future success. In this renewal, we have added a specific postdoctoral training component. We
expect our trainees to remain in the program for 1-2 years, at which time we expect that they will have
obtained independent funding or transitioned to another research support mechanism. In either case, they
will have a continuing, high-level of support from the program. We seek to build a steadily growing cohort of
scientists with shared goals and interests, that will advance the goals of NIMH for research into the neural
mechanisms of development, disorders and mental disease.

Public health relevance
This project will train researchers in critical areas of research relevant to mental health. The program will support advances in knowledge that will improve the mental health outcomes for those suffering from developmental disabilities and mental disorders, and will advance the research priorities of the NIMH.